PATHOGENESIS OF DISEASES INDUCED BY NON-ONCOGENIC RETROVIRUSES

Retroviruses, including HIV and HTLV, cause neurological disease. The goal of this project is to understand how retroviruses adversely affect the central nervous system. We are utilizing mouse retroviruses which cause rapid neurologic diseases (i.e., 2-3 weeks after inoculation) and have used this system to study the interaction between virus and brain. Entry of virus into the brain: We previously showed that an accessory retroviral protein, glycosylated gag is involved in spread of virus from hematopoietic organs such as the spleen to the brain and liver. We are interested in understanding the function of this protein. To this end we have successfully expressed glycosylated gag in trans in vivo, and have shown that a mutant virus which itself does not express the protein, now exhibits neuroinvasiveness. We plan to use this model to carry out structure-function studies which should uncover the region of the molecule which is involved in promoting infection of the brain. Envelope protein and microglial cells in neurodegeneration: It is generally recognized that microglial cells, the macrophages of the central nervous system, are intimately involved in the pathogenesis of retrovirus-induced brain diseases. In the case of the neurovirulent murine retroviruses the role of microglial cells is based on the temporal and spacial relationship between infected microglial cells and spongiform lesions. In the case of HIV encephalopathy, there is in vitro evidence that microglial cells exposed to SU protein elaborate substances toxic for neurons in vitro. Previous work indicated that implantation of microglial cells infected with a neurovirulent MuLV induced focal spongiform degeneration in vivo. We now have evidence through implantation of neuroectodermal progenitor cells, that neither infected astrocytes, oligodendrocytes nor neurons induce such lesions. In addition, implantation of these progenitor cells expressing only a "neurovirulent" envelope protein either in a secreted or membrane-associated form also did not induce lesions. These studies indicate that the envelope protein is not directly neurotoxic when expressed in the brain and that infected microglial cells are required for induction of neuropathology in vivo. Role of cytokines: Two chimeric murine retroviruses which utilize the same receptor but differ in their envelope sequences have both been shown to infect the brain, and appear also to infect the same cell types in the brain. Both induce an intense diffuse astrocytosis without evidence of any inflammatory infiltrates, but only one causes clinical neurologic signs. This paradigm appears ideally suited for identifying virus/host interactions which may provoke neuronal dysfunction. Using the sensitive multiprobe RNAase Protection Assay, we are screening cytokine mRNA for evidence of differential expression in the disease state.